EFFECTS OF ISOPROTERENOL &ADENOSINE ON AUTONOMIC NERVOUS SYSTEM

Because arrhythmia are profoundly influenced by autonomic tone, isoproterenol and adenosine are essential tools in the cardiac electrophysiology laboratory. Frequently arrhythmia are induced only during isoproterenol, the investigators expect to determine if a unique phase of sympatho-vagal balance occurs during washout which could explain this window of inducibility. Because adenosine causes first antiadrenergic changes and then sympathomimetic changes, this study will delineate the time course of both and allow optimum utilization in the cardiac electrophysiology laboratory of the autonomic changes produce by adenosine.